Non-Invasive Neuromodulation Device for the Treatment of Alcohol Use Disorder

Abstract
Excessive alcohol consumption is the third leading cause of death in the United States, and approximately 15
million Americans suffer from alcohol use disorder (AUD). AUD also economically expensive, with $249 billion
spent annually for costs related to healthcare, lost work productivity, and crime. Despite the high prevalence of
AUD and its severe consequences, less than 20% of those with AUD receive any treatment, mainly due to key
drawbacks of current treatment options. Guidelines for AUD treatment include pharmacotherapy, behavioral
intervention, or both. Meta-analyses consistently demonstrate that first-line AUD medications (naltrexone and
acamprosate) are only moderately effective, at best. AUD pharmacotherapies also have common side effects
that limit acceptability to patients. Similar to medications, behavioral interventions, such as cognitive behavioral
therapy (CBT), provide only small/moderate treatment benefits. In addition, programs often require abstinence,
which can be a barrier as many AUD patients prefer non-abstinent goals. Recent preclinical and clinical research
has shown that acupuncture of a peripheral nerve pathway can significantly modulate craving-, reward-, and
withdrawal-related responses for drugs of abuse. We, thus, hypothesize that peripheral nerve stimulation can be
an effective treatment for AUD through its direct effects on craving, reward, and withdrawal. Thus, TheraNova
has developed the Empower Neuromodulation System, a portable, easy-to-use transcutaneous electrical nerve
stimulation (TENS) device for non-invasive nerve stimulation as a treatment for AUD. The Empower
Neuromodulation System consists of a small, wearable Controller and gel electrodes that are temporarily
adhered to the skin to stimulate the underlying nerve. Our Phase I clinical study with AUD patients demonstrated
that the Empower treatment significantly reduced alcohol consumption (mean reduction = 29%, p=0.026), alcohol
craving intensity (mean reduction 21%, p=0.001), and anxiety (mean reduction = 31%, p<0.001) (vs. baseline
week measurements) after only two weeks of treatment. While promising, this was a two-week, open-label study,
so a longer, sham-controlled pivotal trial is needed to rigorously verify that Empower offers a comprehensive
AUD treatment. In Aim 1 of this proposal, we will first update the design of the Empower Neuromodulation System
and conduct all bench testing required to support an FDA submission. Then, in Aim 2, we will conduct a multi-
site, sham-controlled pivotal clinical trial to evaluate the safety, effectiveness, and acceptability of Empower as
a treatment for AUD. The data obtained through this work will support FDA clearance, enabling
commercialization of the Empower Neuromodulation System as a comprehensive treatment for AUD.

Public health relevance
Narrative Approximately 15 million Americans suffer from alcohol use disorder (AUD), but current treatment options have low-to-moderate effectiveness and all suffer from one or more key drawbacks. In this Phase II SBIR, we propose further development of the Empower Neuromodulation System, a non-invasive, home-use neuromodulation treatment for AUD. The data obtained through this work will support FDA clearance, enabling commercialization of the Empower Neuromodulation System as a comprehensive treatment for AUD.